Miniaturizing Time Resolved Fluorescence Measurements Using Entangled Photons and On-Chip Photonics

Fluorescent biosensors and microscopes can measure voltage, calcium, neurotransmitters, and other
essential endogenous or exogenous biomarkers. The standard practice is to record the change in biosensor
fluorescence intensity over time. The signal can be affected by fluctuations in sensor levels between cells
and animals, laser power, imaging position, and other unavoidable experimental factors. Time-resolved
fluorescence (TRF) and fluorescence lifetime imaging (FLIM) solve this problem by measuring lifetime
instead of intensity. TRF allows well-calibrated measurements of biosensor analyte levels by being resistant
to intensity fluctuations. TRF also enables new measurement modalities based on the fluorophore’s local
environment, ranging from endogenous fluorescence signals to the near-endless continuum of exogenous
FRET and lifetime-based biomarkers. However, portable implementation of lifetime-based approaches is
hampered by a pulsed laser’s cost, physical size, power draw, and required domain-specific expertise.
The proposal uses integrated photonics to create entangled photon sources that enable highly multiplexed,
low-cost, low-power, and portable measurement of TRF/FLIM in a universal package. The Cushing lab has
discovered that creating entangled photons with integrated photonics can be used for fluorescence lifetime
measurements with both quantum and practical advantages. The advantages include improved tuning range
(>500 nm) per source, temporal resolution (< 0.1 ps), a CW-like approach that reduces phototoxicity effects,
alignment-free operation through a photonic back end, and <1 cm2 physical size – all powered by the
equivalent of a mW laser pointer. Entangled TRF, therefore, appears ideal for portable or wearable,
miniaturized TRF and FLIM approaches. The technology can be compared to emerging LED-based
miniaturized devices, which lack the ability for high wavelength multiplexing without multiple sources nor
the time resolution to distinguish multiple biomarkers and their environmental response. By starting with a
CMOS-cost-scalable package using thin film photonics, our innovation will significantly improve health
equity by making TRF and FLIM accessible to a broader range of biological and medical researchers.
The specific aims of the proposal include 1) optimizing the entangled photon source for excitation-
wavelength and temporally multiplexed fluorescence lifetime sensing, 2) extending entangled TRF toward
shorter wavelength excitations by transitioning from lithium niobate to lithium tantalate, and 3) integrating
on-chip photonic elements for a miniaturized TRF architecture. Collaborators specializing in FLIM and
TRF biosensors evaluate each stage of the grant with regard to application, including testing in their labs,
to ensure realistic criteria are used in addition to photonic metrics. The proposed research is the first step
towards a multiplexed platform that brings TRF and FLIM to broader health applications, including portable
medical diagnostics and in-vivo or miniaturized sensors, all using the cost scaling of integrated photonics.

Public health relevance
PROJECT NARRATIVE Time-resolved fluorescence is a powerful tool for accurate and environment-sensitive measurements in biosensors and FLIM, but the size, complexity, and power draw of pulsed lasers limit its potential for miniaturization and portability. Our proposed solution uses on-chip photonics for entangled photon time- resolved fluorescence approaches. The entangled photon approach has superior multiplexing bandwidth (>500 nm), temporal resolution (0.1 ps), and coherent beam properties compared to current miniaturized LED sources while maintaining their compact <1 cm2 size, low power draw, and high flux - making it an ideal approach for miniaturized, point-of-contact and eventually wearable applications.